Groundwork for a Synchrotron MicroCT Imaging Resource for Biology (SMIRB)

Abstract In the current supplement, we request funds to build and test a custom lens and camera system that enables an unprecedented combination of 12 mm diameter field-of-view at 0.7 µm isotropic voxel resolution. Our objective is to expand the utility of synchrotron microCT proposed in the parent award to enable full- volume 3D imaging at cell resolution samples as wide as 12 mm, such as human biopsies and mouse tissues, and to create a web-based integrative bio-atlas that provides a critical means of comparisons, multi-scale, and multi-modal integrations. This effort will significantly broaden the application of synchrotron microCT to a wide range of sample sizes and model system samples, which will yield 3D image data critical for the development of computational phenomics. We intend to make these 3D images publicly available on a web-based “bio-atlas” to function as a foundation for the creation of a multi-model multi-modal reference atlas, inclusive of histology, 3D image data, and -omics data. We will achieve these goals through three interrelated specific aims: 1) confirm the theoretical resolution and imaging speed of the lens and camera system in our in-house microCT system using real samples, 2) compare image quality and image speeds obtained with the lens and camera system using synchrotron sources with those on our local source, and 3) create a integrative web-based infrastructure to host 2D and 3D data and develop multiple tools for viewing, labeling, and cross-referencing to allow comparison-based validation of animal models of human disease. The pan-cellular, full volume nature of the 3D images will add invaluable spatial information to histology, immunohistochemistry, immunofluorescence, and transcriptomics, proteomics, and metabolomics data.

Public health relevance
Narrative We are requesting funds to greatly accelerate our goal of quantitatively defining normality and disease across all organisms at unprecedented resolution. The supplement will cover the costs of a new, custom-designed lens system that will allow us to create “3D histology” images of cm-size samples at subcellular resolution. The supplement will also allow us to create the foundation for a powerful new tool that will function like a “Rosetta Stone” for biology: a user-friendly web interface that will someday allow new ways to 1) visualize high- resolution imaging data in 2D and 3D, 2) access cross-referenced molecular data in the context of the whole organism, and 3) facilitate validation and use of animal models of human biology and disease by integrations across model systems, imaging modes, and molecular data and ultimately, comparisons with human data.